Patient-Oriented Research in Arginine Deficiency Syndromes

This K24 application entitled “Patient-Oriented Research (POR) in Arginine (Arg) Deficiency Syndromes” seeks
5 years of support for protected time to expand the principle investigator's (PI) mentoring activities, promote her
career development & provide momentum to advance the applicant's research evaluating Arg therapy in sickle
cell disease (SCD) and beyond. Arg is a nutritional supplement & obligate substrate for the production of nitric
oxide, a potent vasodilator that becomes depleted during episodes of SCD-related pain and contributes to vaso-
occlusion. The PI has completed a single-center randomized, double-blinded, placebo-controlled trial (RCT) of
Arg therapy in 54 children with pain requiring hospitalization. She observed a reduction in opioid usage by over
54%, lower pain scores, and a clinically relevant trend towards decreased length of hospital stay in children who
received 5 days of Arg therapy compared to placebo. She has an active research program that includes a FDA-
sponsored Phase 2 RCT and a NHLBI-supported pharmacokinetics study of Arg therapy to treat SCD-related
pain that is currently enrolling patients. The PI proposes to extend these studies to a definitive multi-center Phase
3 trial. Pain in SCD is the leading cause of hospitalizations, emergency room (ED) visits, missed school & is
associated with an increased mortality rate. There are no current therapies to treat the underlying mechanisms
of pain, with interventions limited to hydration and analgesia. The PI hypothesizes that Arg is a safe &
inexpensive nutritional supplement with narcotic-sparing effects in pediatric SCD patients and pain. Her current
and future study aims will determine the safety & efficacy of arginine therapy to reduce time to pain crisis
resolution and total parenteral opioid use (mg/kg) in children with SCD & pain. This proposal will provide essential
data for product development and will ultimately help gain FDA product approval for SCD if benefits of Arg
therapy are confirmed in follow-up studies. Acute care of patients with SCD & pain in the ED is a neglected area
of research. The results of this proposal may ultimately lead to a change in clinical practice for patients with SCD
in both the ED & inpatient hospital wards. ED-based studies and novel therapies that target mechanisms of pain
are needed in SCD. In addition, the PI is highly committed to performing POR focused on nutrition science & in
growing her mentorship reach to include a diverse group of undergraduate's, graduate & medical students, post-
doctoral fellows & junior faculty in clinical nutrition research, having mentored scholarly activity for over 35
mentees already during the course of her career. During the 5-year grant, the candidate will also participate in a
number of mid-career leadership & mentorship courses, choosing curriculums that will help advance the
candidate as an educational leader & mentor within academic medicine. The environment at Emory University
is ideal to foster these goals, and will enhance the career development of the applicant as a mentor champion
in integrative medicine in partnership with the Atlanta Clinical and Translational Science Institute, thereby
enabling her to train mentees in the field and increase the pool of evidence-based integrative clinical scientists.

Public health relevance
Project Narrative: Pain is the hallmark of sickle cell disease (SCD), and is the leading cause of hospitalizations, emergency room visits, missed school, and is associated with an increased death rate. We found that patients with SCD and pain had low levels of the amino acid arginine in their blood, and we also demonstrated that arginine supplementation during acute pain events significantly reduced the amount of narcotics needed to treat sickle cell pain in children and dramatically improved pain scores at discharge compared to placebo. We propose to investigate the benefits and safety of arginine for the treatment of patients with SCD and pain in a randomized, placebo-controlled clinical trial where neither the patient nor the clinical team know which therapy the patient is receiving, since Arginine is a promising new therapy that could change the way we treat acute pain in SCD.